NIDA CTN BS/WN Yr17 S1 CTN0109A1

ABSTRACT Our overall goal will be to pilot the development of an Innovative Development of Research Engagement Manual (I-DREM) that maps out sustainable solutions that would benefit the recruitment of Black individuals into substance use disorder (SUD) clinical trials and move the meter towards the goal of making diversity in clinical trials a standard part of the SUD clinical research model. Aim 1: To develop a protocol to increase recruitment and retention of Black participants into SUD trials that maps out concrete steps to aid researchers, from planning stages all the way through trial implementation. Aim 2: To develop training modules for research teams to enhance cultural competency and facilitate recruitment and retention of Black individuals into SUD clinical trials.

Public health relevance
PROJECT NARRATIVE The challenges of recruiting Black individuals for clinical trials have been discussed in various research studies for medical conditions like cancer. Substance abuse adds additional barriers to both recruitment (e.g., concerns about social, legal, or employment consequences of disclosing one’s substance use) and retention (e.g., stigma, relapse, ongoing legal involvement). While significant attention has been devoted to identifying inclusion barriers, the current proposal looks to redirect efforts away from documenting barriers to developing sustainable solutions with an Innovative Development of Research Engagement Manual (I-DREM) to map out concrete strategies to increase recruitment and retention of Black individuals into clinical trials for substance use disorders (SUD).